Genomics and Bioinformatics Core

Genomics and Bioinformatics Core (GBC): PROJECT SUMMARY/ABSTRACT
The Genomics and Bioinformatics Core (GBC) delivers cost-effective analytical genomics solutions and
bioinformatics analyses for intellectual and developmental disabilities (IDD) researchers. The objective of the
GBC is to maximize the potential for researchers to develop new insights, diagnostics and therapeutic
interventions for individuals with IDD by removing obstacles for leveraging genomic methods.
The GBC has a dedicated staff led by internationally known investigators with an established track record in
multidisciplinary research with a focus in genomics and bioinformatics. The genomics group of the Core provides
equipment, expertise and training to support efficient utilization of genomics technologies. The bioinformatics
group develops computational tools for omics data, designs best practices for utilizing large datasets, and
provides training in biomedical data sciences. Advances in genome sequencing technologies enable researchers
to identify changes that relate to IDD.
The aims of the GBC are to provide access to, and training in, cutting edge techniques and technologies that
can result in insights into the genetic basis of IDDs, to capture high resolution single cell level data of gene
expression that contribute to development and dysregulation in IDDS and to maximize the impact of genomic
information in understanding IDD by integrating genomic data with clinical, behavioral and pathophysical
knowledge. In this way, the GBC will contribute to the understanding of the molecular physiology of IDDs and
create new opportunities to develop diagnostics and therapeutic interventions.